Next generation all-optical toolkits for functional analysis of neuropeptide dynamics in neural circuits

Project summary
The mammalian brain is remarkably dynamic and can quickly adjust its functional state in response to changes
in the environment. For example, when a salient event occurs, the brain enters a mode that enhances memory
formation. Such brain state changes occur too rapidly to be due to anatomical rewiring. Instead, they are
thought to arise from the action of neuromodulators (NMs) and neuropeptides (NPs). Unlike small-molecule
NMs, such as acetylcholine and monoamines, NPs are not generally released as the major neurotransmitter
from specialized neurons and they are not recycled after release. Instead most neurons synthesize and
release NPs in addition to fast transmitters such as glutamate and GABA, and peptide clearance is governed
by diffusion and proteolysis. Although long utilized as anatomical markers, our understanding of NP signaling is
only cursory. Insights into the cellular code of peptidergic communication are only now emerging from large-
scale transcriptional profiling studies that reveal the distribution of peptides and their receptors across cell
types. These have revealed a differentiated anatomic distribution of NP-receptor pairs across cell types that
poise NPs as important mediators of trans-cellular communication in neural circuits. However, the functional
significance of NP signaling is extremely difficult, if not impossible, to study using current tools, which do not
reveal the timing and location of NP signaling in vivo, or the consequences of NP signaling on neural circuit
activity. Thus, new technologies are needed to enable gain- and loss-of-function studies that precisely target
the normal location and timing of NP activity in behaving animals.
To overcome these technical barriers, we assembled a multi-disciplinary team to develop, validate, apply, and
disseminate next-generation optical toolkits for functional analysis of the spatiotemporal dynamics of NP
signaling during behavior. Our toolkits include: 1) photoactivatable agents to rapidly deliver NPs (or drugs that
target NP receptors) to their sites of action with high spatiotemporal precision; 2) genetically-encoded NP
sensors to report when NPs are released and over what temporal and spatial scales they act: 3) new optical
and genetic approaches for cell- and region-specific recording and manipulation of NP action using these
probes at multiple sites in the mammalian brain simultaneously.
Combining these methods with functional studies in behaving animals, we aim to establish paradigms for
determining the necessity and sufficiency of NP signaling for the modulation of circuits in vivo. We will
determine the context and location of NP release, the ensuing spatiotemporal pattern of NP receptor activation,
and the effects this has on neuronal physiology and behavior. We will actively disseminate these toolkits to the
neuroscience community. Broad applications in various brain regions and species will reveal the dynamic
contribution of NPs to the control of brain circuits and plasticity. This knowledge will provide building blocks and
pave the ways to refine theory and develop novel therapeutics for neurological and neuropsychiatric disorders.

Public health relevance
Project Narrative Peptide neurotransmitters trigger brain-state changes that shape physiological processes ranging from pain perception to social bonding, and are implicated in neuropsychiatric conditions such as addiction, anxiety, eating disorders, sleep disorders, and depression. This work aims to establish new experimental approaches for studying neuropeptide signaling in the mammalian brain that will reveal how neuropeptides contribute to behavior and how they are compromised in disease. 1